Developing Innovative Cell and Gene Therapy Strategies to Treat Fanconi Anemia

ABSTRACT/SUMMARY:
Fanconi Anemia (FA) is the leading cause of inherited bone marrow failure (BMF) affecting thousands of patients
worldwide. While allogenic (allo)-hematopoietic stem cell transplantation (HSCT) outcomes have been improving
for FA patients, these treatments currently cause significant morbidity and mortality in part due to the non-specific
and genotoxic chemotherapy and/or irradiation conditioning traditionally used pre-transplant. This is especially
problematic in FA patients due to their exquisite sensitivity to DNA damage which results in DNA interstrand
crosslinks (ICLs) and heightened risk of malignancies in all patients. Our long-term goal is to develop alternative
non-toxic FA therapies using cell and gene therapy. Towards this goal, we have generated HSC-targeted
conditioning approaches using monoclonal antibodies (mAbs) and mAb-drug-conjugates against the CD117
HSC cell-surface protein that clear host HSCs without non-specific tissue damage. However, from this research
we have found that host HSC depletion is not critical in the FA setting. This has been further observed in the
setting of autologous FANCA lentiviral gene therapy and somatic mosaicism, which have both shown that a small
number of initial functional hematopoietic stem and progenitor cells (HSPCs) can stabilize hematopoiesis in FA
patients. The overall objective of this work is to leverage distinctive strategies that elude the immune system
to safely establish functional HSPCs in the bone marrow that can maintain hematopoiesis in the FA setting. The
preliminary data supports a central hypothesis that stable hematopoiesis with ability to repair DNA ICLs can
be established in FA without the use of genotoxic chemotherapy or irradiation due to the competitive advantage
of functional HSPCs over failing FA HSPCs. This hypothesis will be tested through three specific aims in FA
mice: 1) Achieving and optimizing haploidentical in utero HSCT without use of any conditioning, 2) Evaluating
post-natal HSCT with immune conditioning alone, and 3) Developing HSC and systemic CRISPR-based base
editing correction methods using engineered virus-like-particles (eVLPs) to stabilize host FA cells. The proposed
research is both innovative and significant because it will identify multiple strategies that safely enable
stabilization of hematopoiesis in the FA setting that will subsequently be translated into non-genotoxic therapies
for FA patients. These novel approaches that enable functional HSC correction using both cell and gene therapy
strategies are aimed at treatment of FA at different stages of hematopoietic disease, with the additional capacity
to uniquely correct FA mutations in non-hematopoietic tissues. This work will have a major impact on improving
treatment for FA patients and findings from this research will subsequently be utilized to improve the treatment
of millions of people worldwide that suffer from diverse hematopoietic and genetic diseases.

Public health relevance
PROJECT NARRATIVE: The proposed research aims to: 1. Explore the competitive advantage of functional hematopoietic stem cells (HSCs) over failing Fanconi Anemia (FA) HSCs, and 2. Leverage distinctive strategies that elude immune responses to enable development of non-genotoxic cell and gene therapy treatments that can be used in FA settings. We anticipate this research will result in the elimination of chemotherapy and irradiation from the treatment of FA patients which will reduce the severe short-term and long-term toxicities that these patients currently experience and are particularly vulnerable to given their inherited DNA-repair deficiencies. Discoveries derived from this work will subsequently be utilized to improve the treatment of millions of people worldwide that suffer from various grievous blood and genetic diseases, and hence the proposed research is relevant to the NIH’s mission to reduce illness and disability.